Critical Role of Endothelial DRP1 in regulating metabolic, microvascular, and cardiac function

Project Summary/Abstract:
Microvascular endothelial-dependent vasodilation in response to flow is achieved by the release of nitric oxide
(NO) in healthy individuals but is mediated by hydrogen peroxide (H2O2) in individuals with coronary artery
disease (CAD). Mitochondria are potent producers of reactive oxygen species (ROS), including H2O2, under
physiological conditions, but overproduce ROS in cardiometabolic pathologies. Mitochondrial fission and
fusion are known regulators of ATP and ROS production. Mitochondrial fission is primarily mediated by and
dependent on the GTPase, dynamin-related protein 1 (DRP1). Hyper-fission, due to increased levels of or
overactivation of DRP1, has been implicated in promoting cellular dysfunction in various cardiometabolic
diseases. Our preliminary data indicate that blocking DRP1 may have vascular benefits for individuals with
CAD and that the overexpression of endothelial DRP1 contributes to vascular dysfunction in both humans and
rats. We therefore hypothesize that DRP1 and mitochondrial fission may be important regulators of endothelial
vascular function. The overall goal of this proposal is to assess the role of endothelial DRP1 in vivo using a novel
rodent model that drives the overexpression of a DRP1-GFP transgene specifically in the vascular
endothelium. Aim 1 will investigate whether DRP1 mediates mitochondrial fragmentation and metabolic
changes in the endothelium in both isolated endothelial cells and intact blood vessels. Aim 2 will determine if
upregulated endothelial cell DRP1 leads to functional damage in the microvasculature and the heart.

Public health relevance
Project Narrative Despite the clear link between oxidative stress and cardiac disease, antioxidant treatments have been unsuccessful in lessening the high morbidity and mortality rates of cardiac disease alluding to the fact that increased oxidative stress may be secondary to disease pathology rather than causative. This application aims to assess whether upregulation of DRP1 contributes to the development of vascular endothelial dysfunction that subsequently progresses to cardiac damage, mitochondrial dysregulation, and metabolic dysfunction independent of increased formation of reactive oxygen species (ROS). The proposed studies use a novel rodent model to test the hypothesis that increased endothelial DRP1 leads to increased mitochondrial fragmentation, changes in metabolism, increased ROS production, and functional changes in the microcirculation and the heart.